Airborne metals, neurodegeneration, and dementia in the Adult Changes in Thought study

Project Summary
1) Objectives: We will define associations and pathways through which exposure to PM2.5 and metals
contribute to dementia-associated neuropathology (DAN), incident dementia, and cognitive function. We will do
so by leveraging resources from the Adult Changes in Thought (ACT) study, an ongoing, prospective cohort
study of brain aging and dementia in older adults who are cognitively intact at enrollment. Every two years
since 1994, ACT has collected vetted data on dementia, other brain health measures, physical health, lifestyle,
medications, and residential history for over 5000 participants, following them until incident dementia or death.
At each timepoint, ACT assesses dementia using the Cognitive Abilities Screening Instrument (CASI) and
consensus diagnosis using DSM-IV criteria. AD is also assessed based on NINCDS criteria. For participants
who consent to autopsy (~25%), ACT performs a neuropathological examination of their brains, including
confirmation of dementia diagnoses. Our study will build on these data and resources to achieve 3 primary
aims: (1) to characterize PM2.5 and metal concentrations within the olfactory bulb (OB), olfactory tract (OT), and
brain tissues of ~140 human donors to establish whether the OB is a pathway through which air pollutants
reach the brain; (2) to investigate the OB as a pathway for DAN within the OBs and brains of these donors; and
(3) to assess the association of PM2.5, metals with incident dementia - including for pathologically-defined AD,
μVBI, LBD, and mixed dementia – and cognitive function, controlling for key confounders and examining effect
modification by sex, race/ethnicity, socio-economics, and health conditions and mediation by health conditions.
2) Approach: We will test our aims following a multi-disciplinary approach that relies on (1) our detailed
analysis of brains and OB for particles, metals and DAN indicators for ACT participants who consented to
autopsy and (2) our epidemiological analyses of the association of long-term ambient PM2.5 and metal
exposures with incident dementia, AD, μVBI, and LBD for the entire ACT cohort and for the subset with
neuropathology confirmed dementia diagnoses. For both, we will leverage ACT’s rich database of clinical and
functional health measures, behaviors, and residential histories. We, for example, will use the residential
histories to estimate long-term ambient PM2.5 and associated metal exposures for each ACT participant using
novel spatio-temporal models. We will also use health and behavioral data to control for key confounders and
predictors and health data to assess modification and mediation of the pollutant-dementia associations.
3) Expected Results: We will provide new evidence of the risks posed by airborne metals to incident dementia
and of the pathways through which airborne metals cause damage. In so doing, results from our study will help
identify targeted interventions to block pathways to dementia by type and mitigate the severe and growing
burden of AD and other dementias.

Public health relevance
Project Narrative Our study will use a multi-disciplinary approach to provide critical, new information about the impacts of airborne fine particle and metal exposures on dementia-associated neuropathology (DAN) and incident dementia (including Alzheimer’s Disease (AD), microvascular brain injury (μVBI), and Lewy body disease (LBD)), and the pathways through which they do so. Results from our study will further our understanding of whether and how airborne metals contribute to DAN and dementia.